Monitored Anesthesia Care and Soft Tissue Infiltration with Local Anesthesia for Older Adults with Hip Fracture: A Multi-Center Feasibility Randomized Clinical Trial

Project Summary/Abstract
Delirium, characterized by fluctuating disturbances of cognition, is common in older adults undergoing hip
fracture surgery. Anesthesia may exacerbate delirium severity, especially in patients with dementia who are at
heightened risk for delirium onset. Monitored anesthesia care with soft-tissue infiltration with local anesthesia
(MAC-STILA) is a novel approach that involves anesthesiologist titration of intravenous sedation to a level that
preserves spontaneous breathing followed by surgeon administration of a local anesthetic injected directly into
the surgical site. MAC-STILA may provide significant benefit to hip fracture patients by avoiding adverse effects
of traditional anesthesia approaches but has not been widely tested. We propose a multi-center clinical trial to
demonstrate feasibility of randomizing older hip fracture patients to MAC-STILA versus the current standard of
care involving general anesthesia and to determine efficacy of MAC-STILA for reducing incidence and severity
of post-operative delirium. The trial will be conducted at 6 hospitals and coordinated by the Major Extremity
Trauma Research Consortium. Using the Delphi approach, we will first achieve consensus on standards for
MAC-STILA among a panel of orthopedic surgeons and anesthesiologists at 6 participating hospitals to
facilitate reproducibility and evaluation. We will then enroll and randomize 140 patients, stratified by baseline
cognitive impairment. We will examine aspects of trial feasibility including recruitment rate, rate of crossover to
a different anesthesia approach, factors associated with treatment crossover, and data completeness. We will
examine the effect of MAC-STILA compared with general anesthesia on delirium incidence and severity using
validated cognitive assessments through post-operative day 5 or time of discharge. We will also explore the
treatment effect on delirium among patients with baseline cognitive impairment and by sex. Secondary
outcomes include intraoperative physiologic parameters (e.g. blood pressure, heart rate), post operative
complications, postoperative pain and narcotic use, cognitive function at 30- and 90-days post discharge, and
30 and 90-day mobility, disability, and mortality. The goal of this study is to demonstrate feasibility and establish
the preliminary data needed to support a larger, rigorously designed multi-site effectiveness trial.

Public health relevance
Project Narrative Delirium is common in older adults undergoing surgical treatment for hip fracture, especially in older adults with cognitive impairment. Monitored anesthesia care with soft-tissue infiltration with local anesthesia (MAC-STILA) is a novel anesthesia approach that may reduce severity of delirium, but it has not been widely tested. We will conduct a multi-center clinical trial to demonstrate the feasibility of randomizing patients to MAC-STILA versus general anesthesia, determine efficacy of MAC-STILA for reducing incidence and severity of post-operative delirium, and explore treatment effects among patients with cognitive impairment.